EVALUATION OF DONORS OF KIDNEYS FOR TRANSPLANTATION

This a follow up study to determine the general health of individuals who have donated a kidney to a relative with chronic kidney failure and to measure the function of the remaining kidney.